Quantitative Stepwise Analysis of RNA Interference

DP2GM105453‐01 MYONG, SUA GRANT TRANSFER APPLICATION For all transfer applications include also a statement indicating whether the overall research plans/aims have changed from the original submission, and, if so, provide updated information. The overall research plans/aims have not changed from the original submission.

Public health relevance
DP2GM105453‐01 MYONG, SUA GRANT TRANSFER APPLICATION PROJECT NARRATIVE Our proposal involves developing novel single molecule platforms which allow quantitative and stepwise analysis of RNAi pathway and opens a new way of assessing and predicting siRNA efficacy. When engineered into a device, such technique can be adopted by research laboratories and clinical practices for designing siRNA for high silencing potency for disease treatment.